X-ray nanotomography for scalable connectomics

Project summary/abstract
Current gold-standard methods for dense tissue reconstruction rely on volume electron
microscopy. As electron penetration depth into tissue is limited to a few 100s of nm, this requires
tissue sectioning or milling, presenting significant scalability challenges for reliable continuous
image acquisition. Importantly, while automatic segmentation methods have seen substantial
improvements in recent years, manual proof-reading still provides a significant cost and time
overhead that is particularly driven by the interfaces of physical sections.
X-rays penetrate macroscopic samples, allowing for largely non-destructive imaging of tissues.
Large scale synchrotron facilities can provide high-brightness coherent X-rays at wavelengths in
the sub-nanometer range, enabling coherent imaging with nanometer scale 3D resolution.
Recent developments in synchrotron technology have seen further increase in coherent photon
flux by orders of magnitude at “4th generation” synchrotrons. Theoretical calculations have
demonstrated that this puts X-ray imaging of whole mouse brains with 20 nm isotropic resolution
in reach.
Here, we will leverage the first high-energy realisation of such a 4th generation source at the
European Synchrotron Research Facility (ESRF). Our proposal is based on the recent decision
of ESRF to dedicate a new beamline to the development of X-ray connectomics, aiming for
routine acquisition of mm3 volumes with 20 nm resolution in <2 days and ultimately imaging of
500 mm3 with 20 nm resolution within <3 months.
Our preliminary work shows that efficient full-field X-ray tomography of brain tissue can already
today achieve a resolution sufficient to delineate synapses and fine neurites. In this proposal we
will further develop and optimise full-field X-ray tomographic approaches including sample
preparation, data acquisition, reconstruction and analysis strategies to further enhance resolving
power, scalability and segmentability in order to enable whole mouse brain X-ray connectomics.
We will use the existing nanoimaging beamline ID16A at ESRF to pilot these techniques and
refine data acquisition and analysis protocols. We will then design and implement a new
instrument including beamline optics, sample stage and detection systems to create the next
generation, synchrotron-based microscope for connectomics at the new beamline. This will be a
facility readily accessible to researchers world-wide and furthermore enable the efficient
construction of X-ray connectomics beamlines at other synchrotrons that are undergoing the
transition to 4th generation sources in the coming years such as APS, PSI, ALBA and Diamond.

Public health relevance
Project Narrative Imaging entire biological tissues with subcellular detail is of fundamental importance for the understanding of biological processes in health and disease. Here we will develop an X-ray imaging facility that will allow comprehensively visualizing ultrastructure in large volumes such as entire mammalian brains in a reliable, non-destructive way. As an accessible and efficient facility, it will enable researchers to e.g. compare the wiring of the brain in health and disease.